Functional roles of the human microbiome and metabolome in oral cancer

SUMMARY
Head and neck cancer (HNC) remains a lethal disease despite concerted efforts to improve its diagnosis and
treatment. Although smoking, drinking, and HPV infection are closely linked to HNC, emerging evidence also
suggests that changes in the human microbiome are associated with HNC. However, little is known about how
altered microbiota affect HNC pathogenesis or its treatment. The oral cavity, which is directly relevant to the
local microenvironment in HNC, harbors one of the most complex and diverse microbiomes of all human
anatomical sub-sites. However, how the oral microbiota shapes the local and systemic environment in HNC
pathogenesis is completely unknown.
Our long-term goal is to determine the functional role(s) and mechanisms of action of the microbiome in HNC
and to translate these findings into novel preventative and therapeutic strategies. In the proposed study, we will
extend and deepen previous studies of human microbiota in HNC, focusing on a prevalent form of HNC with
high mortality and morbidity, oral squamous cell carcinoma (OSCC). Our Specific Aims are as follows 1) To
define OSCC-associated metagenomic and metabolomic signatures in treatment naïve OSCC cases and non-
OSCC controls and 2) To determine whether microbiota transfer from human OSCC cases to mouse models
promotes tumorigenesis and characterize the underlying molecular mechanisms. Our approach is innovative
because it represents a departure from the status quo by utilizing unique experimental mouse models and state-
of-art technologies to move beyond observational human studies to delineate the molecular, cellular, and
immunological mechanisms induced by the human microbiome in OSCC pathogenesis. The proposed research
is significant because it is expected to advance and expand understanding of how the microbiome as a whole,
as well as specific microbial taxa, genes, and pathways, impacts OSCC. Ultimately, such knowledge has the
potential to be developed into effective therapies for OSCC patients, a pressing need given the significant
incidence and poor prognosis of this disease.

Public health relevance
PROJECT NARRATIVE This proposed research is relevant to public health because understanding the molecular mechanisms by which human microbiota, as well as microbial and host metabolites, contribute to oral cancer is expected to result in identification of biomarkers and potential targets for intervention. These findings are likely to be translated into novel and effective diagnostic and treatment options for patients with oral cancer and head and neck cancers, in general. The proposed research is relevant to the NIH mission to develop fundamental knowledge that will enhance health, lengthen life, and reduce illness and disability; in particular, our research pertains to understanding the causes, diagnosis, prevention, and cure of human diseases.